Georgetown University Lombardi Comprehensive Cancer Center Support Grant

OVERALL: PROJECT SUMMARY
The Georgetown Lombardi Comprehensive Cancer Center (LCCC) is the only National Cancer Institute (NCI)-
designated Cancer Center headquartered in the District of Columbia (DC). LCCC was established 52 years ago
by Georgetown University (GU) to impact the cancer burden in a highly diverse and disadvantaged catchment
area (CA) through high-impact cancer research. In 1974, LCCC first received comprehensiveness status and in
2019 realized Consortium status with the John Theurer Cancer Center (JTCC) of Hackensack Meridian Health
(HMH). LCCC’s vision is to impact our diverse CA, the nation, and beyond by pushing scientific knowledge,
creativity, and application; serving all with compassion, equity and respect; and preparing individuals who will
devote themselves to reducing the severity of cancer on the individual, family, and community through improved
access to care. Louis Weiner, MD, a leading medical oncologist and translational scientist with expertise in
immuno-oncology, has led LCCC since 2008. During the project period, Weiner led the development of a
visionary Strategic Plan for the Consortium that emphasizes transdisciplinary collaboration and community
impact around five unifying themes: (1) Translation; (2) Health Disparities and Community Engagement; (3)
Leadership in Clinical Research and Clinical Care; (4) Signature Training and Education; and (5) Organization,
Resources and Diversity, Equity & Inclusion. LCCC also (1) received unprecedented financial investments and
commitments from GU, HMH and MedStar Health, its academic medical center partner; (2) appointed 5 new
Associate Directors and 6 Program Co-Leaders, increasing leadership diversity across the Consortium; (3)
infused additional funding and expanded efforts in Community Outreach and Engagement (COE), Cancer
Research Training and Education Coordination (CRTEC) and Diversity, Equity and Inclusion (DEI); (4) increased
the diversity of its membership, committees, leadership and other forms of representation; (5) reviewed and
enhanced CCSG Programs and Shared Resources for greater scientific impact; and (6) promoted
transdisciplinary collaboration and bidirectional engagement of the communities we serve. LCCC successfully
executed a multi-year recruitment effort to increase Cancer Focus and research depth across the Consortium,
while applying more rigorous methods to ensure cancer relevance; and expanded clinical trials capabilities
including investigator-initiated trials across the Consortium. LCCC’s 109 members have a total of $38.7M in
annual cancer-focused funding, of which $21.9M is peer-reviewed, including $13.8M (63%) from NCI, $6.4M
(29%) from other National Institutes of Health (NIH) agencies, and $1.7M (8%) from other peer-reviewed sources.
This represents a 61% increase in peer-reviewed funding and a 41% increase in NCI funding over the prior
project period. LCCC Members published 975 peer-reviewed papers in the first 4 years of the current project
period, of which 29% were high-impact (≥10). During the project period 5783 patients have accrued (through
12/31/22) to interventional trials.

Public health relevance
Project Narrative The Georgetown Lombardi Comprehensive Cancer Center (LCCC) is applying for this renewal of its CCSG as a consortium cancer center with the John Theurer Cancer Center of Hackensack Meridian Health. LCCC’s vision is to impact our diverse catchment area, the nation, and beyond by pushing scientific knowledge, creativity, and application; serving all with compassion, equity and respect; and preparing individuals who will devote themselves to reducing the severity of cancer on the individual, family, and community through improved access to care. LCCC remains the only NCI-designated comprehensive cancer center based in the nation's capital.